Inflammation-associated Autophagy Dysfunction

Project Summary
Chronic TNF-driven inflammation and deregulated hemostasis are characteristic of sickle cell disease (SCD).
Despite TNFα's pivotal role in the pathophysiology of SCD and its role in deregulating hemostasis in other
inflammatory diseases, the precise mechanisms by which it disrupts the hemostatic balance in SCD remain
poorly understood. In response to TNFα, platelets accumulate larger amounts of mitochondria. Such
modification is paralleled by functional changes that deregulate platelets' hemostatic role. More recently, it has
been demonstrated that in SCD, a proportion of mature red blood cells (RBCs) contain dysfunctional
mitochondria that promote hemolysis. Given that both RBCs and platelets originate from common
hematopoietic precursors (Megakaryocytic Erythroid Progenitors), TNFα may disrupt common regulatory
pathways in platelets and erythroid cells responsible for the clearance of mitochondria. Hence, we hypothesize
that TNF-driven inflammation in SCD blocks autophagy and mitophagy in platelets and reticulocytes, 1) leading to the
accumulation of dysfunctional mitochondria and deregulation of platelet’s hemostatic function and 2) disrupting the
clearance of mitochondria by reticulocytes that consequently generate mature RBCs with retained mitochondria. Our long-
term goal is to identify inflammation-mediated mechanisms that disrupt autophagy in platelets and erythroid
cells in SCD. Ultimately, we aim to develop novel therapies to effectively address these pathophysiological
aspects of the disease.

Public health relevance
Project Narrative Millions of people around the world have sickle cell disease (SCD). One of its many complications is the inability to maintain the hemostatic balance. This project seeks to identify the mechanisms that underlie this imbalance and develop new ways to restore it.